Evolvable essentiality in the pan-genome of Streptococcus pneumoniae and its mechanistic and evolutionary consequences

Summary
No single gene exists in isolation, rather the genes in the genome make up an intricate network of interacting
components that come together in different pathways and processes to generate a phenotype. Even small
genetic changes can have far reaching consequences for an organism’s phenotype, let alone when large
numbers of genes are different between strains, which is the case for those species with a pan-genome. For
instance, a strain of the bacterial pathogen S. pneumoniae on average contains ~2100 genes, while the entire
species harbors >4400 genes, which means that two random strains may differ by the presence and absence of
hundreds of different genes. Within a biological network, many genes are dispensable, which within a pan-
genome are mostly those genes that are variably present. In contrast, about 10-15% of genes in a bacterial
genome are essential and keep an organism’s functionality intact under any circumstance. Due to their acute
importance, essential genes are generally seen as rigid and largely immutable, consequently making them
excellent targets for, for instance, antimicrobial therapies. However, by computationally interrogating thousands
of S. pneumoniae strains, and 17 clinical strains experimentally, we have created a large dataset that shows that
not all essential genes are ‘created equal’. Specifically, essential genes do not always seem to be present in all
strains, and depending on a strain’s background, can sometimes be experimentally deleted. This raises the
hypothesis that the essential gene concept is much more fluid than assumed and indicates that, under the right
circumstances (i.e., genetic background), essential genes are evolvable and can switch to non-essential. In this
proposal we aim to understand why some genes are essential, while others are not, we experimentally explore
how essentiality can evolve, whether it is predictable, what the possible functional, phenotypic and/or
evolutionary consequences are, and how we can take advantage of evolvable essentiality. Specifically, In Aim
1.1 several genomics tools are used to comprehensively map out evolvable essential genes in S. pneumoniae
by sampling >85% of the genetic diversity in the pan-genome. In Aim 1.2 the evolvability of ~200 genes is
explored with three validated strategies that reflect and uncover the ease in which an essential gene can become
non-essential. And in Aim 1.3 we use machine learning to determine whether essential gene evolvability is
predictable. In Aim 2.1 45 (evolvable) essential genes in cell wall synthesis and associated pathways are
interrogated with CRISPRi-TnSeq to build a detailed interaction network. In Aim 2.2 we engineer paired-strains,
where in one strain a gene is essential, and a near identical strain it is not. And in Aim 2.3 we use the paired-
strains and employ different approaches to assign gene function and identify mechanistic consequences of
evolvable essentials. In Aim 3.1 the paired-strains are used to determine whether there are fitness costs
associated with evolvable essentials, while in Aim 3.2 we determine whether there is a cost to adaptability,
thereby potentially creating a trade-off. Finally, in Aim 3.3 we exploit the pan-genome and our new strain-pairs
in an attempt to design a novel proof-of principle gene-targeting drug screen.

Public health relevance
Narrative While the majority of genes in a genome are dispensable, a relatively small number of genes are essential under any circumstance and are generally seen as rigid genetic components, consequently making them excellent antimicrobial targets. Preliminary work has shown that many essential genes can lose their essentiality depending on the genetic background, making them evolvable. Here we determine what makes an essential gene evolvable, we test whether evolvable essentiality is predictable, what the phenotypic and mechanistic consequences are (especially for cell wall synthesis), whether there are fitness costs and/or adaptability changes and, importantly, we apply our newly found knowledge to design a proof-of-principle gene-targeting drug screen.